Targeting Lipid Clearance Pathways to Promote Repair after SCI

PROJECT SUMMARY/ABSTRACT
After spinal cord injury (SCI), the injury site is filled with cellular debris, especially myelin debris that creates a
very unique lipid-dense environment. Macrophages are the predominant phagocyte that are responsible for
debris-clearance, but this process is not only inefficient, it is also maladaptive. The excessive amount of myelin
debris present at the injury site leads to formation lipid-laden macrophages (a.k.a. foamy macrophages) that
become pro-inflammatory and contribute to tissue regeneration failure. Therefore, understanding the
mechanisms of foamy macrophage formation after SCI may lead to novel therapeutic targets to promote repair
after SCI. In this application, we will investigate the molecular mechanisms of lipid accumulation in foamy
macrophages and how they contribute to fibrotic scar formation at the spinal cord injury site.

Public health relevance
PROJECT NARRATIVE A major impediment to spinal cord regeneration is the failure to clear cellular debris at the injury site, which creates a very unique lipid-dense environment due to abundance of myelin debris. Excessive uptake of lipid in phagocytic cells transforms them into inflammatory cells that contribute to the pathogenesis of SCI. Thus, we propose to investigate the molecular mechanisms the lead to lipid accumulation in foamy macrophages and how they contribute to a fibrotic environment at the injury site.